Translating Molecular and Clinical Data to Population Lung Cancer Risk Assessment

Project Summary
Lung cancer continues to be the most common cancer and reduction of lung cancer related death is
a global priority. The National Lung Screening Trial (NLST) reported that the low-dose computed
tomography (LDCT) screening reduced the lung cancer mortality by 20%, with a trade-off of more
than 95% of false positive results. This underlined our need for a much improved risk prediction
model and higher screening efficiency to balance the benefits and potential harms. Although there
have been substantial efforts in establishing lung cancer risk prediction models, none have taken all
aspects into account and the joint performance of all predictors remains unknown. For those with
CT nodules, currently there is a wide range of clinical protocols on how they are managed, from
watchful waiting to invasive diagnostic procedures. With the usage of LDCT scans rapidly growing
following the NLST report, there is an urgent need to address the issues of (i) who should be
recommended for screening and (ii) what to do when a nodule is found. Our research team is
in the unique position to conduct this much needed work as we have already established extensive
resources for the data elements needed being the lead investigators of the three lung cancer
consortia (International Lung Cancer Consortium, Transdisciplinary Research in Cancer of
Lung, and Lung Cancer Cohort Consortium), and have established collaborations with the lung
cancer CT screening programs in the US, Canada and Europe. The overall goal of this project is to
translate the epidemiological, molecular and clinical data into lung cancer risk assessment and to
improve nodule assessment. Specifically, we will (i) establish an integrated risk prediction model
to identify individuals at high risk of lung cancer, combining personal health and exposure history,
targeted molecular and genomic profile and lung function data based lung cancer CT screening
populations in US, Canada and Europe based on a total of 950 CT-detected lung cancer patients
from cohorts of 46,057 screening individuals; and (ii) establish a comprehensive nodule
assessment models for individuals with LDCT-detected non-calcified pulmonary nodules based on
both 2 dimensional-based and 3D volume and radiomics-based probability models. We will compare
the model performance with the existing classification system such as Lung-RADS and conduct net
benefit and decision curve analysis to assess their clinical usefulness. These models will be very
valuable for the general public, clinicians, researchers and health administrators. It will increase the
efficiency of lung cancer LDCT screening, and reduce unnecessary workup (and patient anxiety) for
those who were found to have LDCT-detected pulmonary non-calcified nodules. The impact of this
project will be wide-spread in our community.

Public health relevance
Project Narrative Lung cancer continues to be the most common cancer and leading cause of cancer death worldwide, and the reduction of lung cancer death remains to be the global priority. Based on the report from NLST showing that low-dose computed tomography (LDCT) can reduce mortality by 20%, several public health agencies have considered population-wide implementation of lung cancer LDCT screening. To balance the potential benefits and harms, our project aims to establish an integrative model for population lung cancer risk assessment for lung cancer screening recommendation, and a nodule assessment model for those with LDCT- detected abnormalities to improve patient management.